Multidisciplinary Pulmonary and Critical Care Training Program

This is a competitive renewal application for continued T32 award funding to support a Multidisciplinary
Training Program in Pulmonary and Critical Care Research at the University of Utah School of Medicine.
The overall goal of this Training Program is to help develop the next generation of MD and PhD scientists to
advance our knowledge of disease processes in the broad arena of pulmonary and critical care medicine, and
to translate this knowledge to care of our patients. This Training Program has been very successful to date;
the great majority of our trainees have excellent publication records, have advanced into active research
careers in academic medicine, and most have obtained funding to support their research. These trainees
include both MD and PhD investigators, addressing questions in basic and clinical research. The Program
faculty for this training program consists of 15 successful scientists drawn from a range of disciplines, including
cell and molecular biology, quantitative research and modeling, outcomes research and human genetics; all
have a strong history of training young investigators and are involved in collaborative translational and cross-
disciplinary research projects. We propose continued support of 4 trainee positions (MD or PhD) for post-
doctoral training, with a minimum of 2 years in the training program. Trainees are recruited from the fellowship
program in Pulmonary and Critical Care Medicine or from the research programs of individual mentors; they
may elect either a basic research or clinical research pathway. Key components of the Training Program
include a mentored individual research project, didactic courses relevant to the trainee’s chosen field and
courses and experiences intended to broaden the trainee’s research perspective. Trainees on the clinical
research pathway typically enroll in a Master of Science in Clinical Investigation degree program. All trainees
will take courses to enhance opportunities for long-term success in a research career (Scientific Writing, Grant
Writing), in the Responsible Conduct of Research and to enhance Rigor and Reproducibility in research. An
important priority for this program is to prepare trainees to function within multidisciplinary teams. Therefore, a
central feature of the Program is the use of individual mentorship committees composed of the mentor, and
both basic and clinical researchers. These committees will continually expose the trainees to multidisciplinary
approaches to key problems, encouraging trainees to look beyond the home discipline of their projects. Based
on the special institutional strengths at the University of Utah trainees, will have extensive opportunities to
develop useful competencies in genetics, biomedical informatics, nanotechnology, geriatrics and
environmental contributions to lung disease. This ongoing program will equip young scientists to pursue future
investigations in pulmonary and critical care medicine, with emphasis on translational science flowing from
mechanistic discoveries and multidisciplinary approaches.

Public health relevance
PROJECT NARRATIVE This Training Program will provide support for MD and PhD trainees to work with a collaborative group of senior scientists, conducting medically-relevant research to address important questions in pulmonary and critical care medicine. Through a combination of a mentored research experience and select graduate-level courses, trainees will be prepared to pursue the new biology of pulmonary and critical care medicine for the future, working as part of collaborative teams linking basic and clinic research to bring new discoveries to the care of patients.